Colorado Dept of Agriculture Application for the FDA LFFM PAR-20-105

The Colorado Department of Agriculture (CDA) Biochemistry Laboratory is seeking funding under FDA funding opportunity PAR-20-105, Laboratory Flexible Funding Model (LFFM) (U19). The Colorado Department of Agriculture is committed to working with the FDA to enhance the capacity and capabilities of state human and animal food testing laboratories to support the overall goal of an integrated food safety system. The CDA supports the goal of the Microbiology Analytical Tracks 1, 2 and 3 and a coordinated sampling program ?to improve food testing surveillance programs through the microbiological analysis of human and animal food products, including food defense?. Our Research Plan for these three Microbiology Analytical Tracks and associated sampling special project establishes that the CDA Biochemistry Laboratory (CDA-BCL) meets the eligibility requirements for this funding opportunity. Furthermore, our research plan demonstrates that the CDA-BCL is competent and currently has the capability to achieve the program requirements and goals outlined in the funding opportunity including the proper laboratory facilities and equipment, credentialed sampling program, organizational structure, personnel, management system, food testing capabilities, and laboratory quality management system. Through overall funding requested, the CDA-BCL will: • Participate in FDA-requested exercises, surveillance and method improvement projects through Microbiology Analytical Track 1 – Food Defense. • Conduct microbiological analyses of 200 human food samples for a single commodity/hazard pair through Microbiology Analytical Track 2 – Human Food Product Testing, and 300 pet treat products for Salmonella through Microbiology Analytical Track 3 – Animal Food Product Testing. • Provide a regulatory sampling program and participate in one year of the NFSDX / ORAPP project through Discipline D: Special Projects 1 and 2.

Public health relevance
FDA Laboratory Flexible Funding Model (LFFM) U19 Colorado Department of Agriculture Division of Laboratory Services Biochemistry Laboratory Public Health Relevance This cooperative agreement research proposal is submitted to FDA on behalf of the Colorado Department of Agriculture in consideration of enhancing and advancing the efforts for a nationally integrated food safety system. The Colorado Department of Agriculture, Biochemistry Laboratory will work with the FDA to protect the safety of the human and animal food supply and to enhance public health. Our work will support the goal “to enhance the capacity and capability of state human and animal food testing laboratories in support of an integrated food safety system” specifically to provide testing and defensible data to strengthen collaboration between FDA and state and local partners.